A role for retinal waves in vascular development

Understanding the signaling between neurons, glial cells, and blood vessels during development is crucial for
designing treatments for vasculature defects, such as the over-vascularization associated with retinopathy of
prematurity. The proposal aims to determine the role of neural-glial-vascular signaling in vasculature
development through two main objectives: Aim 1: Use quantitative approaches to characterize the vasculature
development and to assess how this process is altered in mice with altered retinal waves. We also propose to use
live imaging of vasculature growth to assess the nature of dividing vessel maturation. Aim 2: Establish the
maturation of the glial-vascular unit using two approaches. First, we will use immunofluorescence to assess when
the glial-vascular interface arises during development. Second, we will use two-photon calcium imaging to
monitor the spontaneous calcium transients in glial processes associated with vasculature and establish their
correlation with retinal waves. This research will enable the lab to test novel hypotheses regarding the role of
signaling in vasculature development, which is critical for understanding how neural activity influences normal
and pathological vasculature development.

Public health relevance
NARRATIVE During development, communication between neurons, glia, and blood vessels is crucial for a healthy nervous system, particularly in the retina. The retina's highly organized vasculature and well-characterized timeline of development make it an ideal model for studying cell signaling and vascular development. In this exploratory grant, we aim to develop approaches to test a novel hypothesis: Retinal waves, correlated activity patterns present during early development, play a role in vascular development. This work will contribute to a detailed understanding of the role of neural activity in proper vascularization and how it might go awry during early development.